The Bacterial and Viral Bioinformatics Resource Center (BV-BRC)

The mission of the NIH/NIAID Bioinformatics Resource Center (BRC) program is to accelerate
basic and applied infectious disease research by providing access to cutting edge
bioinformatic tools, knowledgebases, and expertise, ensuring that our knowledge of
pathogenesis can be translated into diagnostics, therapeutics and a public health response
that mitigates the morbidity and mortality resulting from infectious diseases. The current
NIH/NIAID-funded Bacterial and Viral Bioinformatics Resource Center (BV-BRC; Contract No.
75N93019C00076) supported this mission by providing a bioinformatics knowledgebase and
analysis platform covering all bacterial and viral pathogens. In response to the NIAID notice of
funding opportunity, RFA-AI-23- 032, our proposal intends to maintain, improve, and expand
the BV-BRC to combat future infectious disease threats, while maintaining our commitment to
enhance accessibility to the bioinformatics resources and serve the global infectious disease
research community. BV-BRC will support bacteria, archaea, viruses, bacteriophages, as well
as metagenomic analyses, with particular emphasis on human pathogens relevant to
infectious diseases and public health. BV-BRC will continue to support the basic scientific
research necessary to understand the biology of these organisms, their pathogenesis, and
disease processes; support development of diagnostics and therapeutics to combat
pathogenic organisms: and provide a rapid response framework to effectively deal with the
inevitable and unpredictable outbreaks and pandemics. To support these overarching goals,
we propose to extend and enhance BV-BRC through the following four key elements: 1)
Maintain and enhance the BV-BRC knowledgebase to support exponential growth of data and
usage and provide integrated access to omics data, metadata, analysis services and
visualization tools, private user workspace, and user documentation to allow users to analyze
public and private data and share or publish results; 2) Develop innovative tools and
technologies to provide comprehensive services for viral and bacterial bioinformatics,
metagenomics, drug development, and developing AI-driven natural language-based user
interface for interacting with data and tools, with emphasis on improving user experience; 3)
Offer critical bioinformatics expertise, outreach, and training to the research community, with
emphasis on fostering opportunities for students by providing freely accessible training
material and conducting training for educators; and 4) Provide cutting-edge support to rapidly
respond to emerging needs, outbreaks, and pandemics by building on the tools and
procedures developed during COVID-19 and Mpox pandemics and enhancing them to improve
readiness and response to future outbreaks and pandemics.

Public health relevance
The Bacterial and Viral Bioinformatics Center (BV-BRC), a unified knowledgebase and analysis resource, serves over 45,000 infectious disease researchers studying bacterial and viral pathogens by providing integrated access to omics data, analysis services, workspace, and extensive training material. We propose to maintain, extend, and enhance BV-BRC by building innovative tools for comprehensive bacterial, viral and metagenomic analyses, aiding development of diagnostics and therapeutics, developing a next-generation AI- driven natural language-based user interface, and honing tools and procedures for pandemic preparedness. We are strongly committed to enhancing accessibility to bioinformatics resources through our robust training and outreach program, with special emphasis on increasing outreach to students by conducting training for educators.